Exploiting Biased Agonism at the Ghrelin Receptor (GHSR1a) for Opioid Addiction

Abstract
In the U.S., the number of Opioid Use Disorder (OUD) diagnoses has exceeded 2 million. Although existing OUD
medications (e.g., methadone, buprenorphine, naltrexone) ameliorate OUD symptoms and relapse rates, they
are not without problematic side-effects and medication discontinuation remains an issue. Consequently, NIDA
has prioritized the development of novel medications to prevent and/or treat OUD. Among NIDA's "10 most
wanted" pharmacologic targets for OUD is the ghrelin receptor, growth hormone secretagogue receptor 1a
(GHSR1a). GHSR1a is densely expressed within dopamine (DA) neurons of mesolimbic ("reward") system and
its activation leads to increased DA release and enhanced motivation to acquire rewarding/reinforcing stimuli
(e.g., food, drugs of abuse). Like other GPCRs, the physiological effects of GHSR1a depend whether G protein-
or b-arrestin (barr)-dependent signaling pathways are preferentially engaged, a process known as functional
selectivity (or biased agonism). Considerable prior evidence supports that leveraging GPCR functional selectivity
may provide a means by which to enhance pharmacotherapeutic efficacy and/or diminish deleterious side-
effects. The Caron group has previously shown that GHSR1a antagonism blocks hyperlocomotion in cocaine-
sensitized mice via a barr-dependent mechanism in DA neurons. Additionally, the Caron group has also
demonstrated that GHSR1a-induced actin stress fiber formation -- a molecular process integral to the
neuroadaptive changes produced by reinforcing substances -- is barr-mediated. In a large-scale drug screen for
novel GHSR1a ligands coupled with medicinal chemistry, the Caron group in collaboration with NCATS, has
identified a lead compound, 8279, which acts as a GHSR1a-selective G protein-biased agonist and thus,
attenuates GHSR1a-mediated barr signaling. Initial data shows that 8279 reduces basal hyperlocomotion in
dopamine transporter knockout (DAT KO) mice (an animal model of hyperDAergia), but does not affect hedonic
feeding. The objectives of this application are to delineate the mechanisms of G protein-biased ligands at
GHSR1a and interrogate their therapeutic potential in mouse models of opioid abuse. The central hypothesis
is that G protein-biased GHSR1a agonism attenuates opioid-induced neuroplasticity and self-administration via
reduced barr recruitment and/or signaling following GHSR1a activation. This hypothesis will be tested by
pursuing three specific aims using 8279, or its derivatives, as our primary tool compound: 1) Elucidate the
biochemical mechanisms underlying GHSR1a biased signaling, 2) Identify the effects of GHSR1a biased
signaling on neuroplasticity, and 3) Evaluate the effects of GHSR1a biased signaling on opioid-induced behavior.
These three aims will be tested using established GPCR trafficking, protein-protein interaction, and signaling
assays, viral vector-based measures of neuroplasticity in brain tissue, and mouse self-administration. These
studies are significant and novel in that they will provide a thorough preclinical investigation into the potential
therapeutic utility of exploiting GHSR1a functional selectivity for the prevention and/or treatment of OUD.

Public health relevance
Project Narrative Opioid Use Disorder (OUD) is a debilitating and lethal disease that exacts substantial public health and socioeconomic costs. This proposal will seek to identify novel pharmacotherapeutic strategies using the Growth Hormone Secretagogue Receptor to prevent and/or treat the devastating outcomes experienced by patients with OUD.